Exploring Barriers and Facilitators of Employment in Veterans with Opioid Use Disorders

Significance: Living with an opioid use disorder (OUD) can make obtaining and sustaining employment
a significant challenge. Adults who have a current OUD are significantly more likely to be unemployed
and make less income compared to those with past OUD or those without lifetime OUD. For most
individuals in treatment for an OUD, being employed is an important part of their recovery journey.
Employment has several benefits, including reductions in preoccupation with symptoms, social isolation,
risk of suicide, hopelessness, and economic instability, which often results in homelessness. However,
with the advent of the COVID-19 pandemic, a significant number of Veterans have lost their jobs are
currently seeking meaningful and competitive employment. Individual Placement and Support (IPS) is
an evidenced-based supported employment intervention that is considered the gold standard of
vocational rehabilitation. Only one small study has examined the effectiveness of IPS among individuals
with OUD on methadone maintenance (n=45) and found that 50% of the IPS participants gained
competitive employment compared to 5% of the waitlist control participants at 6 months (p<0.001). Prior
to launching a well-warranted large-scale study of IPS for OUD, a better understanding of the barriers,
facilitators, preferences, and employment accommodations in this unique patient population is needed to
better tailor IPS delivery for Veterans recovering from OUD.
Specific Aim: Examine the barriers and facilitators of sustained employment, including evaluation of
employment challenges, occupational functioning, community integration, and quality of life and
satisfaction among Veterans with OUD diagnosis.
Methods and Procedures: This pilot study primarily utilizes a qualitative design, specifically
phenomenology. Quantitative data will also be collected to better understand the patient population and
will include (a) socio-demographic information such as age, level of education, employment history,
income and source of income, housing and experiences with homelessness (b) history of substance use,
(c) mental health- specifically depressive symptomology, (d) occupational functioning, and (e) quality of
life related information. Utilizing phenomenology approach, qualitative interviews will be conducted with
50 Veterans, at least 6 of whom are or will be engaged in IPS services, 6 vocational rehabilitation
specialists (includes 4 IPS specialists), 6 mental health or addiction recovery providers, and at least 6
employers/potential employers who may have or would be willing to employ persons with OUD. The
participants must read and sign an IRB-approved informed consent prior to participating. To conduct the
data analyses, the seven steps to procedural data analysis in phenomenological studies will be utilized.
This approach examines participants associated meanings to the phenomenon under investigation and
provides researchers the ability to identify the emerging themes. Primarily, an inductive thematic
approach will be utilized as the primary method of data analysis.
Conclusion: This SPiRE proposal addresses an area that lacks preliminary data, gathers new
knowledge for an urgent need, informs the refinement of a tailored IPS intervention for OUD, allows an
early career investigator to conduct a small study, allows a senior investigator to explore a new research
area, leverages the investigators’ strengths and expertise, and advances the knowledge needed to
promote successful recovery and reintegration into society for Veterans recovering from OUD, especially
during and after the COVID-19 pandemic.

Public health relevance
The aim of this study is to gather new information from Veterans recovering from opioid use disorder (OUD) about their experiences trying to obtain and sustain a meaningful competitive job. In addition, mental health providers, addiction counselors, vocational rehabilitation specialists, and employers will be interviewed about their views on helping Veterans with OUD find and maintain meaningful employment, especially during and after the COVID-19 pandemic. This information will be used to tailor vocational rehabilitation services. By the end of the study, the investigators will have a better understanding of the barriers and facilitators of employment among Veterans with OUD; thus, will be able to provide recommendations that provide solutions to the barriers and leverages the facilitators of getting and keeping a job. This study advances the knowledge needed to promote successful recovery and reintegration into society through a meaningful well-matched job for Veterans recovering from OUD.